Proteogenomics of Splicing Proteinopathies in Neurodegeneration

PROJECT SUMMARY/ABSTRACT:
Alzheimer's disease (AD) is an irreversible and progressive neurodegenerative disorder that affects
approximately 6.9 million Americans. Despite extensive research and significant investment in developing
therapeutics, there is currently no cure for AD. It is thus urgent to accelerate research efforts to develop effective
treatments. A common feature of AD pathology is the deposition of protein aggregates (proteinopathy).
Identification of these aggregated proteins, along with genetic studies, can provide crucial insights into the
molecular pathogenesis of AD and AD-related dementias (ADRD). This proposal is founded on recent insights
from our comprehensive proteomic analyses of human brain samples, and subsequent in vivo mouse modeling.
In addition to known proteinopathies (Aβ, tau, α-syn, and TDP-43), we have recently identified the aggregation
of U1 small nuclear ribonucleoprotein (U1 snRNP), notably the U1-70K subunit and its N-terminal 40 kDa
fragment (N40K). We have also discovered that the spliceosome pathway is the most enriched pathway in the
AD aggregated proteome. Transcriptomic profiling of human brain tissues has consistently revealed reproducible,
aberrant RNA splicing events in several AD cohorts compared to matched controls. We further demonstrated a
causative role of U1 snRNP dysfunction in neurodegeneration using transgenic mice (N40K-Tg), which
recapitulates N40K insolubility, erroneous splicing events, neuronal degeneration, and cognitive impairment.
Crossing N40K-Tg with the 5xFAD amyloidosis model shows that RNA splicing dysfunction synergizes with the
amyloid cascade to deregulate synaptic proteins and enhance cognitive decline. These findings support our
central hypothesis that U1 snRNP proteinopathy-mediated RNA splicing dysfunction is a key event in AD
pathogenesis. Building on our previous research, we aim to systematically characterize U1 snRNP and other
proteinopathies (e.g., Aβ, tau, α-syn, and TDP-43) along with splicing dysfunction in AD/ADRD using human
brain specimens, mouse models and human iPSC-based 2D neuron and 3D brain organoid models. We will
employ the latest bulk and single cell type multi-omics-based proteogenomics tools. All large-scale datasets
generated will be made publicly available on a unified resource website. Our results will provide crucial AD/ADRD
proteogenomics resources, elucidate the interaction between U1 snRNP with other proteinopathies, and reveal
mechanisms of RNA splicing dysfunction, potentially leading to novel strategies for effective AD/ADRD treatment.

Public health relevance
PROJECT NARRATIVE: Alzheimer's disease (AD) is a debilitating, progressive neurodegenerative disorder affecting an estimated 6.9 million Americans, for which there is no cure. Our proposed study aims to investigate the prevalence of RNA splicing-associated proteinopathy and dysfunction in AD and AD-related dementias (ADRD). By studying the molecular mechanisms in proteinopathy-mediated splicing deregulation in AD/ADRD patient samples, human stem cell-derived brain organoids, and animal models in parallel, we will gain a deeper understanding of AD/ADRD pathogenesis, offering crucial insights that could lead to new therapeutic strategies.